Core C: Biostatistics and Bioinformatics Core

CORE C: PROJECT SUMMARY
The goals of the Biostatistics and Bioinformatics Core are to address the study design and analysis needs of the
Yale SPORE in Skin Cancer projects, the Developmental Research Program (DRP), and the Career
Enhancement Program (CEP), and to address the analytical and data management needs of the Biospecimen
Core. Drs. Kluger and Ma will continue to serve as Co-Directors of this Core and will be assisted by statisticians
and bioinformaticians with unique expertise and extensive experience. The Specific Aims of the Biostatistics and
Bioinformatics Core are as follows. Aim 1: Provide strong biostatistical and bioinformatics support to all SPORE
projects and investigators. The Core will provide timely and comprehensive support to address analytic questions
arising from the SPORE projects. Our service will cover the whole spectrum of the studies, including study
design, data management and analysis, result interpretation, and preparation of manuscripts, abstracts, posters,
and applications. The Core will have regular research meetings with the SPORE investigators and maintain an
open-door policy for all analytic needs. Aim 2: Provide effective data management for all the SPORE projects.
The Core will offer data management services to all projects and investigators and ensure that all NIH data-
sharing regulations are properly followed. This includes deposit of properly curated data to repositories such as
GEO, SRA, dbGaP, and others. Aim 3: Develop innovative biostatistics and bioinformatics methods. Data with
more complex characteristics are and will continue being generated by the SPORE and other studies. The Core
will develop new analysis methods which will facilitate more effective utilization of data and foster melanoma
analytic research. Aim 4: Promote program-specific research opportunities involving biostatistics and
bioinformatics trainees and faculty. The Core will promote opportunities within existing Yale programs and
centers, including the Yale Graduate Program for Computational Biology and Bioinformatics (CBB), Yale Center
for Biomedical Data Science (CBDS), Yale Center for Analytic Sciences (YCAS), and others. During the past
and ongoing funding period, the Core has made significant contributions to research and training, which is partly
reflected in our strong publication record and successes in training postdoc associates and graduate students.
We will continue to do so in the proposed funding period. The Core will borrow strength while not overlap with
that of other SPOREs and Yale Comprehensive Cancer Center (YCC). The Core will also be a key partner in
the SPORE with representation on the Senior Leadership Team and participation in all key meetings.

Public health relevance
CORE C: PROJECT NARRATIVE With a stellar team of bioinformaticians and biostatisticians, the Core will provide the whole spectrum of analytic support to all SPORE projects and investigators. The Core will ensure that all studies are properly designed and executed and that data are properly managed, analyzed, reported, and published.